CE24-001, UNC INJURY PREVENTION RESEARCH CENTER

PROJECT SUMMARY/ABSTRACT
This competing application requests R49 funding to continue the work of the University of North Carolina
(UNC) Injury Prevention Research Center (IPRC) as a CDC-supported Injury Control Research Center (ICRC).
The Center’s mission is to advance the field of Injury and Violence Prevention (IVP) through interdisciplinary
research studies, and by training the next generation of IVP researchers and practitioners. The Center is
organized around three Cores. The Administrative Core, led by Center Director Marshall and Associate
Director Moracco, ensures timely communication and synergy among the three Cores, and between the Cores
and the Center’s Research Projects. The Administrative Core also oversees operational support functions. The
Outreach Core, led by IPRC’s Managing Director for Outreach, Partnerships and Capacity Building
(Taraskiewicz), and mentored by Center Associate Director Moracco, utilizes well-established practice-based
partnerships to conduct programs that build capacity in the IVP workforce. The Outreach Core also ensures
that the Center’s scientific and practice-based products are rapidly disseminated to diverse communities, using
tools and messaging that translate readily into evidence-based practice and policy. The Training and Education
Core, led by Associate Professor Shanahan, implements education and training programs that support and
diversify the future IVP workforce. These include student-led research groups, student fellowships and
internships, formal courses and webinars, and mentoring support. The Center’s Core Faculty, led by Associate
Professor Naumann, are an interdisciplinary group of emerging, mid-career, and established IVP scholars. All
aspects of the Center’s work are infused with a strong commitment to equity and inclusion. The four Research
Projects proposed in this application build upon and extend existing areas of strength among the Center’s Core
Faculty. The four Projects are led by one mid-career investigator (Reyes) and three early-stage investigators
(Austin, Ising, and Naumann). All four Projects include an equity focus area. Three of the four Projects address
the three NCIPC Director’s Strategic Priorities (Project 1: Adverse Childhood Experiences; Project 2: Suicide;
Project 4: Drug Overdose) and each Project addresses at least one NCIPC Research Priority. Projects 1, 3,
and 4 are Translation Science. UNC IPRC has strong Institutional Support from UNC and support from state
IVP leadership and government. The Center is a trusted wellspring of injury and violence knowledge and
expertise, both in-state and nationally. We bring 35 years of ICRC experience and scholarship to bear on
emerging issues and trends in injury and violence. In summary, the Center is dedicated to producing high-
quality IVP science, and ensuring that science is translated into lives saved and improved.

Public health relevance
PROJECT NARRATIVE Injury, violence, and overdose are major public health problems, responsible for more deaths between the age 1 to 44 than any other cause of mortality. The mission of the UNC Injury Prevention Research Center is to advance injury and violence prevention through interdisciplinary research, and by training the next generation of injury researchers and practitioners. The three Cores and four Projects proposed in this application implement Research, Outreach, Training and Education projects and programs that will advance the science of injury and violence prevention, help prepare the next generation of injury prevention professionals, and continue our Center’s 35-year legacy of impactful injury science.